CONTROL MECHANISMS OF HEPATIC GLUCOSE OUTPUT

To examine the interplay between gluconeogenesis and glycogenolysis in the enhanced hepatic glucose output of non-insulin dependent diabetes mellitus and to assess G-6-pase gene in diabetic and nondiabetic man.